Precision Clinical Trial Recruitment to Promote Cancer Health Equity Across Florida

PROJECT SUMMARY
Racial and ethnic minorities represent the fastest growing segment of the United States adult population, yet
they remain significantly underrepresented in cancer clinical trials (CCTs). Low trust in clinical research and
recruitment approaches that fail to address multilevel barriers to CCT participation are key reasons for minority
population underrepresentation. Community health educators (CHEs) improve trust in research among
underrepresented populations, yet relying on exclusively on CHE availability can limit intervention reach.
Virtual CHEs (vCHEs) improve scalability by extending CHE capabilities and capitalizing on remote recruitment
techniques. The purpose of the current project is to increase referral of diverse participants to NCI-supported
clinical trials via a culturally responsive, multi-level intervention that utilizes vCHEs to reach diverse
populations. We will consolidate existing referral channels within the ALEX Research Portal. ALEX offers a
custom experience for clinicians, CHEs, and patients to facilitate CCT referrals. Clinicians can utilize the portal
to refer to CCTs; CHEs can use the portal to create an avatar that can provide introductory information to
patients and schedule video-conference follow-ups; patients, families, and community members can use the
portal to easily navigate to key information and make self- and other-referrals. The ability to streamline
information to patients and CCT referrals to study coordinators is expected to improve the overall referral to
CCTs. The ALEX Research Portal utilizes the adaptive virtual human technology developed at the University of
Florida that provides users with culturally and linguistically tailored CCT information. The ALEX Research
Portal will be developed and launched across three distinct geographic areas of Florida (Gainesville,
Jacksonville, and Miami). This unique collaborative opportunity will provide access to participants
representative of the racial and ethnic diversity of the state as well as cancer centers conducting CCTs
associated with national networks (ETCTN, NCTN). Guided by the Interactive Systems Framework for
dissemination and implementation, our goal is to increase referrals to CCTs by optimizing the ALEX Research
Portal for broad use. The outcome will be an evidence-based intervention that can be widely disseminated to
quickly increase the referral of diverse patients to CCTs. This project will be conducted in three phases: (Phase
I) establish a baseline of referrals and accrual of diverse participants to CCTs across multiple Florida Center
Centers, (Phase 2) adapt and pilot the ALEX Research Portal using a randomized controlled clinical trial, and
(Phase 3) scale the intervention by dissemination via the OneFlorida network. The proposed study will result in
an empirically-tested vCHE Research Portal for increasing trust in CCTs among diverse populations that can
easily be adapted and disseminated across the state to overcome challenges associated with recruiting
diverse participants to CCTs.

Public health relevance
PROJECT NARRATIVE Racial and ethnic minorities represent the fastest growing segment of the United States adult population, yet they remain significantly underrepresented in cancer clinical trials (CCTs). The overarching goal of this proposal is to create an evidence-based, scalable communication strategy to increase referrals to CCTs in Florida by clinicians, community health educators (CHEs), and patients through engagement with the ALEX Research Portal. The Portal will consolidate referral channels, extend the reach of CHEs, and facilitate access to culturally and linguistically tailored resources.